Augmentation of Tissue Perfusion with Ultrasound-mediated Cavitation

SUMMARY
Ultrasound (US) is used for a variety of therapeutic applications. Over a range of different frequencies and
powers, US has been shown to produce to produce modest increases in arterial diameter and tissue perfusion
in animal models of limb and myocardial ischemia. In the initial funding period for this award, we described how
the combination of US with microbubble (MB) contrast agents that undergo inertial cavitation during high-power
contrast-enhanced US (CEU) produces much greater augmentation of limb skeletal muscle perfusion (up to
10-fold) than US alone. Brief CEU cavitation protocols were found to reverse limb ischemia for >24 hrs in
animal models, and a clinical trial in patients with peripheral artery disease (PAD) confirmed that MB cavitation
increases limb perfusion by several fold. In the course of our studies, optimal conditions for these bioeffects
were investigated which mandated us to design novel US pulse schemes and 3-D exposure capability. From a
mechanistic standpoint, we carefully mapped pathways responsible for cavitation-induced flow augmentation
which rely on shear-mediated ATP release from endothelial cells and erythrocytes, with secondary purinergic
vasodilation through downstream mediators (NO, prostaglandins, adenosine). Knowledge of the optimal
conditions and mechanistic underpinnings is critical for our current efforts to apply cavitation and activation of
ATP channels to treat ischemic disease by augmenting flow or by other potentially beneficial anti-thrombotic
and anti-inflammatory effects of purinergic signaling. The overall aim of this renewal is to leverage knowledge
from the first funding period in order to explore the therapeutic role of cavitation and non-cavitation US for
acute and chronic ischemic syndromes. In Aim 1 preclinical models will be used to determine whether limb
flow-augmentation from MB cavitation using previously-optimized pulse schemes can: (a) prevent tissue
necrosis in acute ischemia, with a particular focus on the effect of clinical variables (age, sex, hyperlipidemia,
diabetes), and (b) improve wound healing and limb function in chronic disease. The functional role of purinergic
vascular signaling will be evaluated by using inhibitor strategies or gene--modified models. In Aim 2 we will
determine whether MB cavitation directly augments myocardial perfusion in acute MI using murine models that
allow us to manipulate purinergic pathways, and in primate models that more closely resemble human biology.
We will also study how US-mediated ATP release has the potential to mitigate inflammation, and microvascular
thrombosis upon reperfusion. In Aim 3 we will test whether US energy from multi-element high-power intra-
arterial catheters increases downstream perfusion through shear-mediated purinergic pathways. This Aim is
based on evidence that therapeutic US catheters used in patients with pulmonary embolism can reduce
pulmonary vascular resistance even without clot lysis. Our proposal represents the translational steps for
development of non-invasive therapies for acute and chronic vascular diseases and will form the basis for the
design of clinical trials that we plan to initiate as the key unsolved issues are addressed.

Public health relevance
NARRATIVE The major objective of this project is to develop a new therapeutic approach for immediately increasing blood flow in patients who have severe atherosclerotic or thrombotic diseases that cause a critical lack of blood flow to the heart, legs or lung. The technique involves the application of ultrasound, with or without simultaneous administration of ultrasound contrast agents that cavitate or “ring” in the ultrasound field. These ultrasound effects stimulate the release of substances that cause vasodilation and that reduce both inflammation and thrombosis.